Gene Expression Profiling of Stress Resilient Mice within the Nucleus Accumbens

Project Summary
Chronic stress exposure increases vulnerability to a variety of mental illnesses including depression.
However, not all individuals that experience stress develop depression. Furthermore, the mechanisms that lead
to stress -resilience, the ability to avoid the negative social, physiological, and biological consequences of stress
have yet to be identified. Here, we focus on understanding the transcriptional mechanisms of resilience to identify
genes that may be protective against stress-related disorders to guide drug discovery efforts. The chronic social
defeat stress (CSDS) paradigm in mice has proven to be a highly useful animal model for studying depression-
related behavioral abnormalities. Following CSDS, a subset of mice exhibit depressive-like behavior and
changes in gene expression that recapitulate changes seen in depression patients examined postmortem.
Importantly, this paradigm allows for the distinction of animals that succumb to the effects of the stress, termed
susceptible, from those that do not, termed resilient. Previously published work has identified a gene network in
the Nucleus Accumbens (NAc) that is specific to resilient mice. In this proposal, I will establish a reproducible
pipeline to characterize the regulatory dynamics of resilient-specific gene networks in order to better understand
the transcriptional circuitry that exist within these networks. I will then activate these transcriptional circuits in
stress-naïve mice before subjecting them to CSDS to test their influence on resilience. The proposed research
will provide a framework to study the transcriptional mechanism(s) of resilience by providing mechanistic insight
into the transcriptional circuitry regulating stress resilience in mice. Together these aims will, for the first time,
establish a novel experimental approach for studying the control over resilience by a complex network of genes
as opposed to standard approaches which interrogate one gene at a time. This approach is designed to be
applicable to any brain region, animal model, or network-based bioinformatics approach.

Public health relevance
Project Narrative There is currently no standardized way to identify a population of resilient individuals, thus animal models like chronic social defeat stress must be used to study stress resilience. By identifying the transcriptional changes that lead to stress resilience in rodents, we will shed light on genes that may potentially be protective against depression in humans. The goal of this work is to establish a reproducible pipeline that can be used to study transcriptional mechanism of stress resilience.